Translational control underlies nutrition and metabolism in health and disease

PROJECT ABSTRACT / SUMMARY:
Fatty acids (FAs) are essential signaling molecules that induce cellular metabolic reprogramming in addition to their
conventional roles as energy fuel. Elevated FA during fasting is the primary fuel for the body and an essential substrate
to generate an alternative energy source, ketone bodies. However, excessive plasma FA levels in obese or diabetic
patients are associated with inflammation, insulin resistance, and cardiovascular diseases. Consequently, understanding
the functional role of FAs in cells will uncover novel physiological mechanisms in the health and pathogenesis
of metabolic diseases, leading to new therapeutic approaches for disease prevention and treatment. Our
compelling preliminary data reveal a novel signaling role for FAs in regulating a specific translation network to
induce the synthesis of proteins that are important for ketogenesis upon fasting and inflammation in
hyperlipidemia. Fasting can lead to wide-ranging health benefits, including weight loss, improved insulin
sensitivity, enhanced brain function, and even offer protection against cancer. Fasting triggers the body to switch its
source of energy from glucose to ketone bodies (KBs). KBs are an alternative energy source that is mainly generated
in the liver from fatty acids stored as fat. Despite decades of work, how fasting signals elicit changes in gene
expression at the level of the proteome to establish metabolic programs that underlie lipid catabolism and production
of ketone bodies remain unknown. Our findings remarkably show that while global translation is downregulated
during fasting, hepatocytes selectively remodel the translatome to sustain lipid metabolism and ketogenesis. We
uncovered a new signaling pathway, induced by FAs directly binding to the AMP-activated protein kinase (AMPK),
that upregulates the translation of hundreds of mRNAs, that are under pervasive translational regulation that was
missed by conventional transcriptomics analysis. In this pathway, we found the rate limiting enzyme of ketogenesis,
Hmgcs2 and the master regulator of lipid metabolism and ketogenesis in the liver, peroxisome proliferator-activated
receptor alpha PPARa to be under translational control. We mechanistically uncovered that the phosphorylation of
the major cap binding protein, eukaryotic translation initiation factor (P-eIF4E) is induced during fasting and is
essential for regulating ketogenesis and ketone body production. Interestingly, our published and unpublished
findings have further also demonstrated that P-eIF4E is activated during high fat diet and is critical for lipid
accumulation and inflammation upon a high fat diet. Thereby P-eIF4E is a node of convergence downstream of
changes to fatty acids both in nutrient deprivation such as fasting as well as nutrient overload. In this grant, we will
investigate three outstanding questions: 1) What are the molecular mechanisms that establish a specific tailor-made
translation program underlying fasting? 2) What is the signaling pathway responsible for fatty acid-induced activation
of eIF4E during fasting, and the molecular mechanism underlying FA induced AMPK activation? 3) We will leverage
our expertise in polysome sequencing and genome wide translation control to characterize the metabolic
programs that are regulated at the translation level downstream of P-eIF4E during the development of fatty liver
(NAFLD) and nonalcoholic steatohepatitis (NASH). The results from these experiments in combination with our
ability to pharmacologically target P-eIF4E will provide new therapeutic interventions for metabolic dysfunctions.

Public health relevance
PROJECT NARRATIVE: This proposal investigates a new role for phosphorylation of the major cap binding protein eIF4E in fasting and high fat diet. The clinical relevance of our study is the ability to pharmacologically inhibit eIF4E activity in metabolic dysfunction associated with excess of ketogenesis such as diabetic ketoacidosis, fatty liver and liver inflammation underlying high fat diet. Together these findings will unveil how posttranscriptional regulation controls physiological metabolic process underlying fasting and high fat diet and its therapeutic implications.